Identification and Development of Novel Influenza M2 Inhibitors

DESCRIPTION (provided by applicant): Influenza virus is a Category C biodefense pathogen of global public health concern because it causes 3-5 million cases of severe illness every year, and because of the potential for the emergence of new, highly pathogenic strains that could cause pandemic disease. To date, there have been only two successfully-exploited influenza viral drug targets and only four approved drugs. The M2 H+ ion channel has been shown to be necessary for viral infectivity, and suppression of its activity is a well validated anti-viral strategy. The compounds amantadine and rimantadine inhibit M2 and have been used as influenza therapeutics for the past 40 years. However, many currently circulating influenza strains now exhibit resistance to them. New drugs that inhibit M2 via novel mechanisms of interaction therefore have significant potential as influenza therapeutics. However, conventional methods for studying the activity of ion channels are poorly suited to high-throughput screening techniques for identifying new inhibitors. Until now, this has largely precluded the development of new classes of M2 inhibitors. Integral Molecular specializes in developing novel strategies for manipulating and studying integral membrane proteins, including ion channels. We have developed a novel technology for monitoring the activity of M2 that we have shown to be well-suited to high-throughput screening (HTS) applications. Having successfully developed a suitable HTS assay for M2 screening, the current application proposes to use it to identify and develop novel M2 inhibitors.

Public health relevance
A modified budget (PHS forms 4 and 5) Please note that our revised Aims do not include the use of any animals (as originally proposed). Also, as discussed with our Program Official, Amy Krafft, our revised Aims and budget have been designed to complement, rather than overlap, our existing SBIR grant, R43 AI079856. This R43 grant (submitted after U01AI078500) essentially proposed the first step of the U01 grant, so the revised U01 Aim starts where the R43 Aims leave off. The revised U01 Aim has also been designed to enable completion within one year by focusing on the chemistry of the influenza inhibitors being developed, rather than on the more costly and time-consuming animal work. A negotiated indirect cost rate of 38.5% (of direct costs excluding subcontractor costs above $25,000) was used for budget calculations. Please feel free to contact me for additional information as needed. Regards, Benjamin Doranz 215-966-6018 [email] Modified Project Summary/Abstract Section Influenza virus is a Category C biodefense pathogen of global public health concern because it causes 3-5 million cases of severe illness every year, and because of the potential for the emergence of new, highly pathogenic strains that could cause pandemic disease. To date, there have been only two successfully-exploited influenza drug targets and only four approved drugs. The M2 H+ ion channel has been shown to be necessary for viral infectivity, and suppression of its activity is a well validated anti-viral strategy. The compounds amantadine and rimantadine inhibit M2 and have been used as influenza therapeutics for the past 40 years. However, many currently circulating influenza strains now exhibit resistance to them. New drugs that inhibit M2 via novel mechanisms of interaction therefore have significant potential as influenza therapeutics. However, conventional methods for studying the activity of ion channels are poorly suited to high-throughput screening techniques for identifying new inhibitors. Until now, this has largely precluded the development of new classes of M2 inhibitors. Integral Molecular specializes in developing novel strategies for manipulating and studying integral membrane proteins, including ion channels. We have developed a novel technology for monitoring the activity of M2 that we have shown to be well-suited to high-throughput screening (HTS) applications. Having successfully developed a suitable HTS assay for M2 screening, we are now using it to identify and develop novel M2 inhibitors. Modified Specific Aims Section Influenza virus is a Category C biodefense pathogen of global public health concern because it causes 3-5 million cases of severe illness every year, and because of the potential for the emergence of new, highly pathogenic strains that could cause pandemic disease. To date, there have been only two successfully-exploited influenza drug targets and only four approved drugs. Of these drugs, two are no longer recommended for routine use because of the increasing prevalence of viral resistance against them, and the remaining two have overlapping mechanisms of action. Thus, there is an urgent need for new pharmaceuticals to expand the limited arsenal of anti-influenza therapies. The M2 H+ ion channel is necessary for viral infectivity, and suppression of its activity by the drugs amantadine and rimantadine is a well validated anti-viral strategy. However, the majority of currently circulating influenza strains now exhibit resistance to these drugs. New drugs that inhibit M2 via novel mechanisms of interaction therefore have significant potential as influenza therapeutics. However, conventional methods for studying the activity of ion channels are poorly suited to high-throughput screening techniques for identifying new M2 inhibitors. Integral Molecular specializes in developing novel strategies for manipulating and studying integral membrane proteins, including ion channels. We have developed a novel technology for monitoring the activity of M2 directly within viral particles. We have shown that structurally intact M2 ion channels can be incorporated into non-infectious virus-like particles (VLPs), that they are capable of conducting ions, and that their activity can be sensitively measured using standard fluorescence detection platforms. This technology has been used to develop a cell-free assay of M2 activity that is well-suited to high-throughput screening (HTS) applications. M2 proteins from diverse strains of influenza have been tested in 384-well microplate format, and this assay demonstrates a robust capability for detecting M2 inhibitors (Z' >0.5). Having successfully developed this HTS assay, we are now using it to identify novel M2 inhibitor compounds that can be developed into pre-clinical candidates. The revised Specific Aim of this proposal is: I. Optimize and Characterize Lead Compounds. Hits identified from HTS will be chemically optimized to improve their potency, bioavailability, and safety. Using structure activity relationship (SAR)-based medicinal chemistry, we will synthesize chemicals with improved physical, inhibitory, and pharmacological properties. Optimized leads will be tested for improved efficacy using the M2-VLP assay, and then for inhibition of virus infection and non-specific cytotoxicity. The most promising compounds will be physically characterized to predict their bioavailability and pharmacological properties. Modified Public Health Relevance Section The product that will result from this proposal is a novel small molecule inhibitor of influenza. The inhibitors developed in this proposal will target a validated influenza molecular target, M2, and overcome the major obstacles faced by the adamantane drugs because compounds will be screened for potency against a number of M2 variants to maximize the chances of developing a broad-spectrum influenza inhibitor. M2 is critical to the influenza life-cycle, suggesting that there is substantial therapeutic potential for next-generation inhibitors of M2 activity. By Scottli at 10:26 am, Aug 03, 2009 C. Research Support Benjamin Doranz R44 GM072379 (B. Doranz, PI) 1.2 cm this grant +7.2 cm = 8.4 ttl effort September 2008-August 2011 20% (2.4 mo) NIH/NIGMS $304,295 Detection of GPCR Function in Cell-free Nanoscale System The goal of this project is to develop a product that will measure the ability of a ligand to activate (not just bind) G protein-coupled receptors (GPCRs) in a cell-free, nanoscale format. The end-product will serve as an alternative to living cells for de-orphaning and screening for drugs against GPCRs, particularly within array-based and miniaturized detection formats. R44 GM076779 (B. Doranz, PI) August 2007-July 2010 20% (2.4 mo) NIH/NIGMS $435,862 A Tool for Modeling the Structure-Activity of Chemokine Receptors and Other GPCRs The goal of this project is to develop a product that will facilitate structural modeling of G protein-coupled receptors (GPCRs). The end-product, the SARray, will enable structural and functional interactions of drug candidates with GPCRs to be determined at the detailed level of amino acid side-chain interactions. R43 AI079856 (B. Doranz, PI) June 2008-May 2010 20% (2.4 mo) NIH/NIAID $186,870 Identification of Novel Influenza Inhibitors The goal of this project is to identify inhibitors against the M2 ion channel of influenza, which is required for productive influenza infection. A high throughput screening assay will be used to measure M2 H+ transport directly within non-infectious virus-like particles in order to identify novel small-molecules targeting this validated drug target. This project overlaps the Aims of the original submitted U01 grant, but does not overlap the revised Aim of the U01 grant, which will use the results of this R43 proposal as a starting point for medicinal chemistry and pharmacological characterization of hit compounds against influenza M2. R44 GM068322 (B. Doranz, PI) September 2005-August 2009 20% (2.4 mo) NIH/NIGMS $286,163 A Cell-free System for Assaying Ion Channel Function The goal of this project is to develop a product that will measure cardiac ion channel activities, particularly K+ and Na+ voltage-gated channels, without the need for living cells. The end product will be a detection reagent that can be used for diagnostics to detect unwanted drug reactivity with cardiac ion channels (the leading cause of drug withdrawal) and for drug screening to identify new therapeutics that modulate ion channel function. Program Director/Principal Investigator (Last, First, Middle): Doranz, Benjamin FROM DETAILED BUDGET FOR INITIAL BUDGET PERIOD DIRECT COSTS ONLY PERSONNEL (Applicant organization only) NAME ROLE ON PROJECT Months Devoted to Project THROUGH 10/1/09 SALARY REQUESTED 9/30/10 FRINGE BENEFITS DOLLAR AMOUNT REQUESTED (omit cents) Cal. Mnths Acad. Mnths Summer INST.BASE Mnths SALARY TOTAL Benjamin Doranz Soma Banik Chida Sulli PD/PI Scientist Scientist 1.2 12 12 150,000 65,000 60,000 15,000 65,000 60,000 0 0 0 15,000 65,000 60,000 SUBTOTALS CONSULTANT COSTS 140,000 0 140,000 0 EQUIPMENT (Itemize) 0 SUPPLIES (Itemize by category) Molecular Biology ($13,000) Glass and plasticware ($18,000) Chemicals and reagents ($11,000) VLP Preparation ($8,000), Chemical synthesis ($10,000) TRAVEL PATIENT CARE COSTS INPATIENT OUTPATIENT ALTERATIONS AND RENOVATIONS (Itemize by category) 60,000 3,000 0 0 0 OTHER EXPENSES (Itemize by category) 0 CONSORTIUM/CONTRACTUAL COSTS DIRECT COSTS 209,220 $ 412,220 0 412,220 Form Page 4 SUBTOTAL DIRECT COSTS FOR INITIAL BUDGET PERIOD (Item 7a, Face Page) CONSORTIUM/CONTRACTUAL COSTS FACILITIES AND ADMINISTRATIVE COSTS TOTAL DIRECT COSTS FOR INITIAL BUDGET PERIOD PHS 398 (Rev. 11/07) Page 4 $ Program Director/Principal Investigator (Last, First, Middle): Doranz, Benjamin BUDGET FOR ENTIRE PROPOSED PROJECT PERIOD DIRECT COSTS ONLY BUDGET CATEGORY TOTALS PERSONNEL: Salary and fringe benefits. Applicant organization only. CONSULTANT COSTS EQUIPMENT SUPPLIES TRAVEL PATIENT CARE COSTS INPATIENT OUTPATIENT INITIAL BUDGET PERIOD (from Form Page 4) ADDITIONAL YEARS OF SUPPORT REQUESTED 2nd 3rd 4th 5th 140,000 0 0 60,000 3,000 0 0 0 0 ALTERATIONS AND RENOVATIONS OTHER EXPENSES CONSORTIUM/ CONTRACTUAL COSTS DIRECT 209,220 412,220 0 412,220 $ 412,220 SUBTOTAL DIRECT COSTS (Sum = Item 8a, Face Page) CONSORTIUM/ CONTRACTUAL COSTS F&A TOTAL DIRECT COSTS TOTAL DIRECT COSTS FOR ENTIRE PROPOSED PROJECT PERIOD JUSTIFICATION. Follow the budget justification instructions exactly. Use continuation pages as needed. The proposed budget covers chemical optimization of hit compounds from ongoing screening efforts. Two scientists at Integral Molecular will be coordinating secondary screening of synthesized compounds in vitro, biological testing of compounds (in cell and virus infection assays), and analyzing data from chemical studies. Chemical synthesis and optimization will be outsourced to Ricerca, who will provide medicinal chemistry support and synthesis for 9-12 months. PHS 398 (Rev. 11/07) Page 5 Form Page 5